Training (Core 1) (pp 257-291)

The National Resource for Translational and Developmental Proteomics (NRTDP) will educate our collaborators and fill an unmet need for training within the proteomics community. While there are many courses nationwide that provide hands-on training in bottom-up proteomics technologies, very few provide any substantive training in top-down proteomics, a core technology of the NRTDP. To that end, we have designed four specific aims and categorized them under two driving themes below. Education Opportunities within the NRTDP: These aims seek to teach a large contingent of scientists from diverse backgrounds the basics of top-down proteomics and to promulgate research (performed both within the NRTDP and outside the NRTDP) to a larger community. Within this theme is an annual course in top-down proteomics and an NRTDP seminar series. Opportunities for Extended Collaboration with the NRTDP: These aims will train fewer scientists than the previous two aims, but it will allow for a “deeper dive” into the technology and will offer real opportunities for scientists to return to their home institutions from the NRTDP with an expansive knowledge of the resource’s operations and technologies. Within this theme is a long-term visiting scholar residency program and a shortterm scholar exchange program.